IDALS LFFM Micorbiology Animal Food Product Testing

Project Summary Microbiology ? Animal Food The production of safe, high quality commercial feeds and grain is critical for maintaining Iowa’s livestock inventory, including Iowa’s first in the nation ranking in hogs and egg-laying chickens, third in milk goats, and forth in cattle and calves feed. According to the Institute for Feed Education and Research (IFEEDER), a non-profit founded by the American Feed Industry Associates, Iowa leads the nation with over 21 million tons of total animal food consumed (IFEEDER, 2017). On any given day, there are over 100 million livestock animals consuming feed on Iowa farms (USDA, 2019). The meat, milk and eggs produced from Iowa livestock are consumed across the nation and around the world, which makes the quality of Iowa animal feeds vital to human food safety, as well, For example, in 2018 Iowa exported pork products to 33 countries according to Iowa Economic Development Authority (IEDA, 2019). Chemical and Biological contaminants in feed may accumulate in the tissue and fat of meat-producing animals. As the contaminants move up the food chain, the hazard from the contaminant can be magnified. Animal feed safety also includes food for a special subset of animals—pets. Pet illnesses caused by contaminated food tend to generate a high number of consumer complaints and attract a significant amount of media coverage. Iowa has 20 pet food facilities processing over 490,000 tons of ingredients into pet food every year (IFEEDER, 2020). Two hundred and fifty pet food and pet treat samples will be purchased at retails stores throughout Iowa. The samples will be tested for Salmonella, Bacillus cereus toxin, and Staphylococcal aureus toxins. Two hundred and fifty ruminant feeds will be sampled and tested for violations of the ruminant feed ban by testing for ruminant DNA and by microscopy. IDALS has been testing ruminant feed for prohibited material and pet foods and treats for microbiological pathogens and toxins under an FDA cooperative agreements or contracts since 2010. We hope to continue this fruitful partnership.